THE GENETIC BASIC OF CONGENITAL HEART DISEASE (CHD) IN HUMANS. WHOLE GENOME SEQUENCING

The Genetic Basis of Congenital Heart Disease (CHD) in Humans? is issued in accordance with the terms and conditions of IDIQ Contract Number HHSN268201700006I, entitled “High Throughput Genotyping and DNA Sequencing for Studying the Genetic Contributions to Human Health and Disease.